Cancer Center Support Grant

DESCRIPTION (provided by applicant): The Salk Institute Cancer Center seeks to understand fundamental aspects of biology related to cancer, with the ultimate goal of reducing cancer incidence, morbidity and mortality. The Center includes 22 faculty members doing basic research in the areas of molecular biology and genetics, growth control, and cell and developmental biology. This Cancer Center Support Grant (CCSG) renewal application requests support for professional personnel, planning and evaluation, development, administration, and eight shared resources, including glassware, media, shared equipment, DNA sequencing/quantitative PCR, cytometry and imaging, peptide synthesis, functional genomics (microarray), and animal and transgenic facilities, to support the competitively funded, peer-reviewed research projects in the Center.